BRAIN INSULIN LEVELS AND THE COUNTERREGULATORY RESPONSE

Identify if differing levels of insulin at equivalent hypoglycemia can affect the counterregulatory response in normal and insulin dependent diabetic man. We will also identify how strict glycemic control in IDDM may modify this response.